High resolution analysis of human cerebellar neurogenesis

Human birth defects of the cerebellum are common, poorly understood and can cause significant cognitive
and motor disabilities. Although the mouse has long been a model for human brain development, we recently
discovered several significant differences in histogenesis and developmental patterns between the human and
mouse cerebellum, including the presence of stem cell zones that are present in human but absent in the
mouse. We hypothesize that these zones contribute to the overall increase in cell number within the human
cerebellum which in turn causes a significant increase in size and foliation. These differences have significant
implications for the developmental pathogenesis of human cerebellar disorders. This study aims to better
characterize human cerebellar stem cell populations using histological and transcriptome analysis. We will
begin by carrying out a thorough immunohistochemical analysis to identify important developmental events in
the cerebellar ventricular zone. We will then characterize the morphology and distribution of a newly identified
cell type absent in commonly studied animal models. We will perform rigorous transcriptome analyses of the
developing human cerebellum to define the molecular drivers of these differences. This study leverages our
substantial cerebellar developmental expertise from model organisms with unique access to developing
human cerebellar tissue.

Public health relevance
To better appreciate common cerebellar malformations in humans and the mechanisms leading to these devastating abnormalities, a more comprehensive understanding of the structural and molecular changes driving normal human cerebellar development is required. These studies will fundamentally improve our view and understanding of the biology of both normal and abnormal cerebellar development which will enable improved diagnosis of cerebellar birth defects.